Calcium Signaling Mechanisms in Cardiac Fibrogenesis

PROJECT SUMMARY/ABSTRACT
Cardiac fibrosis is a hallmark of nearly all forms of heart disease, the leading cause of morbidity and mortality
worldwide. However, despite the intensive research, there is no effective therapy for fibrosis, highlighting an
urgent need to identify better therapeutic targets. As cardiac fibroblasts are the principal mediators for TGFβ
induced fibrosis in heart diseases, targeting a fibroblast-specific molecule which is involved in TGFβ induced
fibrosis would be an ideal target. However, fibroblast specific molecules are yet to be discovered. We previously
demonstrated that TRPM7 is a major functional Ca2+ permeable channel in cardiac fibroblasts and plays a key
role in TGF induced fibrogenesis cascade in cultured fibroblasts. TRPM7 is a unique Ca2+-permeable channel
which possess a kinase domain. We have recently discovered that deletion of Trpm7 effectively reduces cardiac
fibrosis thereby protecting hearts against pressure-overload induced heart failure. Interestingly, we found that
deletion of Trpm7 in fibroblasts is necessary to produce the protective effects, indicating that Trpm7 deletion
produces protective effects in a fibroblast-dependent manner. As targeting fibroblasts to inhibit fibrosis has
recently been defined as a novel therapeutic strategy for cardiac fibrosis, we propose that TRPM7 may serve as
a promising therapeutic target for fibrogenesis. Since TRPM7 has both channel and kinase function, one critical
question is whether the channel function or kinase function should be the target for mitigating cardiac fibrosis.
We propose two specific aims to investigate whether TRPM7 channel and/or kinase functions contribute to
TRPM7 mediated fibrogenesis, and how inhibiting channel and/or kinase functions will protect hearts against
fibrosis associated heart diseases. We will apply multidisciplinary approaches including mouse transgenic and
knockout models, molecular biology, biochemistry, patch-clamp, Ca2+ imaging, and various in vitro and in vivo
disease models, as well as fibroblasts from heart failure patients. The results of this proposal will not only answer
the critical questions regarding whether the channel function or kinase activity should be the therapeutic target
for fibrogenesis, but also will reveal novel mechanisms of TRPM7-mediated fibrogenesis in fibrosis associated
heart diseases. More importantly, this proposal will provide translational insights into therapeutic potential of
TRPM7 for pressure overload and ischemic injury induced heart failure.

Public health relevance
PROJECT NARRATIVE Heart disease is the leading cause of morbidity and mortality in the United States and across the world, and cardiac fibrosis is one of the most detrimental factors for a variety of heart disease including hypertrophy and heart failure. However, an efficient therapy for fibrosis-associated heart disease is still an unmet need. We propose to investigate novel mechanisms of cardiac fibrogenesis and to identify potential new therapeutic targets for developing better therapy for fibrosis-associated heart diseases.